NATIONAL NEUROLOGICAL AIDS BANK

Project Summary/Abstract
There is a need for human brain tissues in research to understand the impact HIV and co-morbid conditions
such as opioid use disorders on the CNS. Since 1998, the National Neurological AIDS Bank (NNAB) has
collected brain tissues and data from a cohort of HIV-seropositive (HIV+) participants. The purpose of this
administrative supplement is to continue the ongoing work of NNAB after our no-cost time extension funds are
expected to run out (estimated June 1, 2023) and before the contract is reviewed and negotiated (estimated
late August, 2023. The funds will pay such costs as salary of investigators/staff, supplies, costs of tissue
acquisition, processing, storage, and to ship tissue to approved researchers. Our samples and data can then
continue to be available to investigators through our allocations process until the contracts are approved.

Public health relevance
Project Narrative The National Neurological AIDS Bank (NNAB) is a longitudinal cohort, tissue, and data repository that supports HIV research by providing tissue samples and data worldwide. The previous grant period ended 2/28/2023 and a contract proposal to continue study operations was submitted prior to the end of the project but has yet to be reviewed. Interim funds are necessary to maintain the cohort, pay staff and investigator salaries, support our autopsy, tissue processing, storage and sample shipping services provided by NNAB after the funds from our no cost time extension run out (estimated by June 01, 2023).